Core D - Data Management and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
The SYBIL Data Management and Bioinformatics Core (DMBC) will support the Center's mission at all stages
of research and publication by tracking projects and experiments, facilitating reproducible analysis, developing
bioinformatic tools, and ensuring access and dissemination of data and resources. Research will be accelerated
by the centralization of primary and processed data, models, workflows, and pipelines using a comprehensive
data management platform to connect all Projects and Cores of the program. The DMBC will implement
comprehensive workflows and quality control pipelines to ensure rigor and reproducibility of the data generated
throughout the SYBIL Consortium. Program data and resources will be disseminated through public repositories
and a Center website developed and maintained by the Core. The workflow of the DMBC has been optimized
and improved during the previous FluOMICS Consortium, through facilitating cooperation and the exchange of
data, bioinformatics tools and models between Cores and Projects, resulting in the present integrated structure.
An important goal of the DMBC will be the development of public tools that facilitate the use and reuse of data
generated by both the SYBIL program and the broader scientific community. The availability of systems-level
data in the infectious disease field has grown to unprecedented levels in recent years, particularly during the
ongoing COVID-19 pandemic. However, due to a lack of accessible and easy-to-use tools that provide
consolidated access and perform meta-analyses of large-scale datasets, the vast potential for infectious disease
OMICs datasets to inform design and development of new therapeutic strategies likely remains unrealized. To
help overcome this barrier, the DMBC plans to establish Coronascape, a new tool that enables researchers to
match the network and pathway signatures of their experiments to publicly available host-pathogen data sets
and leverage those data to overcome emerging challenges of an advancing field. Building on the highly
successful Metascape platform previously developed by the DMBC, Coronascape promises to promote the
utilization and reuse of the vast amounts of SARS-CoV-2 data that are publicly available.